MRI contrast agents based on iron as alternatives to gadolinium agents.

Abstract/Summary
Iron coordination complexes are under development as alternatives to gadolinium-based MRI contrast
agents (GBCA) to address the concerns of Gd retention in human bone and tissue. The important role of
iron in human biology, the abundance of the element, and its excellent properties as a relaxation agent
make it an important alternative. Yet, the development of iron agents has lagged well behind that of
manganese alternatives, due to the challenges of iron coordination chemistry. We have developed
innovative solutions to iron-based contrast agents featuring macrocyclic ligands that stabilize a high-spin
trivalent iron center (Fe(III)) as required for a T1 relaxation agent. Our lead compounds are overall
anionic in charge and clear rapidly through a renal pathway in mice. In this effort, we propose to
develop Fe(III) macrocyclic complexes that contain an inner-sphere water ligand with anionic pendants
that produce complexes that are highly soluble in aqueous solution. Both mononuclear and dinuclear
analogs of the iron complexes will be prepared through the addition of protected, sulfonated pendant
groups to the macrocyclic framework. The iron complexes will be further studied as contrast agents in
healthy mice. The pharmacokinetic clearance of the contrast agents will be tracked through T1 weighted
imaging. Enhanced contrast produced by the iron complexes in comparison to Gd(DOTA), as an example
of a commonly used GBCA, will be recorded as an important benchmark. The most promising iron
complexes will be labeled with a stable but rare isotope, 57Fe, to track the retention of iron in mice over
several days, as an important component of contrast agent development. The maximum tolerated dose
at 7 days and 14 days for lead complexes will be studied in mice.

Public health relevance
Narrative Alternatives to gadolinium-based MRI contrast agents (GBCA) would benefit patients who are contraindicated for receiving GBCA including patients with impaired renal function or heart disease. Contrast agents based on iron, an element that can be stored or recycled in the human body are a promising solution. The iron-based contrast agents proposed here are innovative because they are unusual examples of coordination complexes with stabilized high-spin trivalent iron centers that show enhanced contrast and clearance resembling that of common GBCA. Scaling up the synthesis and preparation of iron contrast agents and tracking elimination through incorporation of a stable, rare isotope of iron are important steps towards commercialization.